Lupus Clinical Trials

This research study evaluates subjects with systemic lupus erythematosus (SLE) and their relatives to investigate the pathogenesis and natural history of the disease, as well as the mechanisms leading to enhanced organ damage. Patients are evaluated through a comprehensive history and physical examination. Routine laboratory studies are obtained as needed to assess disease activity or complications, and to monitor for drug-related toxicities. Blood, skin, or urine specimens are requested for research purposes, including genetic studies. In addition, a subset of these patients undergoes several tests to understand the pathogenic changes affecting their blood vessels, as well as the natural history of premature atherosclerosis in SLE. Patients who are eligible for other research studies are offered the opportunity to participate after signing an informed consent form. Any medical care recommended or provided to the patient is consistent with routine standards of practice and provided in consultation with the patient's referring physician. Blood and urine sample collection, as well as cardiovascular testing, are conducted with healthy volunteers for research purposes and to support the identification and validation of new biomarker candidates. Over the past year, we have continued to collect research samples and data, making progress in our understanding of the dysregulated immune system in SLE through various collaborations. The study remains a platform for teaching and training the next generation of rheumatology fellows and post-baccalaureate trainees.